Mechanisms of maladaptive memory formation and suppression in a preclinical model of the comorbidity between PTSD and addiction

Project Summary
There is a high comorbidity between substance use disorders (SUDs) and post-traumatic stress disorder
(PTSD). A consequence of this comorbidity is that exposure to cues associated with trauma in a patient with
PTSD may trigger relapse of drug seeking, even after successful treatment or periods of abstinence. Thus, a
major goal of treatment for both PTSD and substance use disorders is to weaken the ability of environmental
cues to induce relapse. One way to do this is through extinction techniques, in which the relation between the
cue and the drug, or the cue and the traumatic memory, is severed. A major challenge for purely behavioral
approaches to substance abuse and PTSD is that successful treatment with extinction often does not persist
and relapse occurs with time, changes in context, or exposure to stress. Work in our laboratories has focused
on manipulating epigenetic mechanisms to make the learning that occurs during extinction persistent, resulting
in long-term weakening of fear responses (in the case of animal approaches to PTSD) and long-term
elimination of drug-seeking (in animal approaches to substance abuse). However, our work, and most of the
work in the general field of the neuroscience of extinction, comes from preclinical studies of basic mechanisms
of extinction within approaches to PTSD (such as fear conditioning) or addiction (such as drug self-
administration) in isolation; comparatively little is known about how learned fear and drug seeking interact at
behavioral and molecular levels. We have developed a novel model of the comorbidity between PTSD and
addiction in rodents that combines behavioral approaches that are well characterized at behavioral, circuit, and
molecular levels. In this model, rodents receive exposure to a battery of shocks in one context and are tested
for drug-seeking behaviors in a second context. Our preliminary data show that this exposure to a single
battery of shocks causes persistent changes (>30 days) in responsivity to a mild stressor and results in
increased cue-induced reinstatement of drug-seeking after extensive extinction. Thus, this approach captures
a persistent context-independent change in drug-seeking that is not captured in other stress-induced
reinstatement procedures and provides a strong basis for investigating, at a basic level, how reward and
aversive processes interact across long periods of time and, at a translational level, how a single traumatic
experience results in persistent effects on relapse after successful treatment. The three specific aims outlined
in this application are designed to (1) elucidate the persistent behavioral and molecular effects of an acute
trauma, (2) evaluate the post-trauma effects of pharmacological manipulation of a specific histone deacetylase
(HDAC3) in circuits involved in extinction of fear and drug-seeking, and (3) to evaluate the mechanisms
through which HDAC3 manipulations alter relapse after trauma. Our focus on epigenetic mechanisms holds
significant promise for understanding how persistent changes in behavior are established following trauma,
and provides a novel therapeutic avenue.

Public health relevance
Project Narrative This project uses a rodent preclinical model of the comorbidity between post-traumatic stress disorder and substance use disorder to characterize behavioral and molecular/epigenetic mechanisms that contribute to the establishment and reversal of the long-term effects of trauma on drug-seeking behaviors.